Integrated Cancer Genomics Core

ABSTRACT– INTEGRATED CANCER GENOMICS SHARED RESOURCE
The Integrated Cancer Genomics shared resource (ICG) is committed to providing state-of-the-art
instrumentation and protocol support to Duke Cancer Institute (DCI) researchers as these technologies evolve
over time. The ICG expanded to meet DCI needs that encompass microbiome, epigenetic and increase single
cell services provided by three institutionally designated core facilities: Sequencing and Genomic Technologies
Core (SGT), the recently established Microbiome Shared Resource (MSR), and the Molecular Genomics Core
(MGC). By unifying these existing resources for DCI members, the ICG meets its objective to provide one-stop
access to all of the major research protocols and instrumentation platforms used in contemporary cancer
genomics research, including genomics, transcriptomics, microbial studies, and epigenetics.
For over a decade, the ICG has maintained a record of providing updated, state-of-the-art genomic and
transcriptomic services to DCI members. The ICG includes services that are performed by three Duke School of
Medicine (SOM) core facilities. The Sequencing and Genomic Technologies (SGT) and Microbiome Shared
Resource (MSR) perform services within the Duke Center for Genomics and Computational Biology; the
Molecular Genomics Core (MGC) performs services within the Duke Molecular Physiology Institute. The ICG
unifies all of the cancer genomic technologies on campus, providing one-stop access to all of the major research
protocols and instrumentation platforms used in contemporary cancer genomics research. The ICG supports a
wide range of projects from DCI investigators, by providing expert consultation, project management and training
to facilitate access to approaches including SNP discovery, mapping chromatin modifications, single-cell
sequencing, measuring mRNA levels at several scales (single genes, cancer panels, entire transcriptome),
sequencing exomes, identifying DNA methylation, microbiome profiling, and mapping transcription factor binding
sites. By offering the full range of technological platforms, the ICG allows investigators to choose the optimal
solution for their cancer related projects and assists investigators with data quality control, versioning, statistical
analysis, and dissemination for all of these services. In addition, the ICG works with DCI investigators to explore
and establish new technologies which catalyzes the advancement of cancer research.
In 2018, the ICG shared resource provided services to 290 investigators, 29% of whom were DCI members,
accounting for 25% of total usage, from all 8 DCI Research Programs. Use of this shared resource by DCI
Members contributed to 216 publications over the project period, 80 of which were in high impact journals. The
shared resource operates primarily on a cost-recovery basis, with institutional support for a portion of the
operating costs and instrument purchases. Support from the Cancer Center Support Grant allows ICG to provide
DCI members with consultations, assistance with grant and manuscript preparation, and scheduling priority. User
fees for other activities follow School of Medicine guidelines.